Micro Disc A Track 4

Project Summary Discipline A Microbiology Track 4 Whole Genome Sequencing The Michigan Department of Agriculture and Rural Development Microbiology Laboratory is a member of the FDA Genome Trakr program. Through this federal program, the laboratory can genetically sequence the DNA of foodborne pathogenic bacteria, allowing the sequence to be compared with the DNA sequences of similar pathogens. This comparison allows epidemiologists to determine if a pathogen in a food product is the organism causing human illness. This in information can then be shared with food regulatory staff of government agencies, allowing the agencies to remove the contaminated food product from commerce, preventing additional illnesses. It is the goal of the program to whole genome sequence as many historic foodborne pathogens as possible, to be shared with scientists and researchers around the world to determine track foodborne pathogens in an effort to prevent future illness.

Public health relevance
Project Narrative Discipline A Microbiology Track 4 Whole Genome Sequencing The Michigan Department of Agriculture and Rural Development Microbiology Laboratory is a member of the FDA Genome Trakr program. The laboratory is accredited to the ISO17025:2017 standard. As a member of the FDA Genome Trakr program, the laboratory has committed to whole genome sequence a minimum of 400 historic foodborne isolates in a world-wide effort to record the genomic sequences of as many foodborne pathogenic organisms as possible, to aid in tracing the origin of foodborne pathogens causing human illness. Through this effort, human foodborne illness can rapidly be linked to food products which are contaminated with the pathogen.